DP21-001 The Oklahoma Pregnancy Risk Assessment Monitoring System (PRAMS)

Oklahoma Pregnancy Risk Assessment Monitoring System (PRAMS)
Component A Core Surveillance
Project Abstract
The purpose of the Oklahoma Pregnancy Risk Assessment Monitoring System (PRAMS) is to
collect state-specific, population-based data on maternal and child health (MCH) indicators of
high scientific quality that can inform programs and policies related to maternal and infant
health. The overall goal of PRAMS is to reduce maternal and infant morbidity and mortality by
collecting information that can be used to inform
• Maternal and infant health programs
• Health policies
• Maternal behaviors
The CDC began PRAMS in 1987. Oklahoma is one of four original PRAMS sites and is one of
only three sites to have continuous data collection for over 30 years.
Long Term Objectives
Oklahoma PRAMS provides data for a variety of MCH issues. The goal of the study is to reduce
the prevalence of maternal and infant morbidity and mortality. PRAMS can accomplish this by
providing on-going, state-wide preconception, pregnancy, and postpartum specific data. No
other state-wide study focuses on the pregnancy and postpartum experience, making PRAMS a
unique and necessary data source for the state.
Research Design and Methods
PRAMS contacts new mothers two to six months after delivering a live birth. The sample is
drawn from the Oklahoma live birth registry. The PRAMS Project utilizes a mixed mode
surveillance system, meaning respondents are sent up to three mail survey packets, followed by
telephone contact for nonrespondents. Oklahoma stratifies by maternal race, oversampling
African American, American Indian and Hispanic mothers. A response rate of 55% in all strata is
required in order to weight the data to the annual birth cohort. Mail packets consist of the
PRAMS questionnaire and return envelope, an informed consent sheet, a resource directory, an
incentive (Mail 1 only), and a reward sheet (listing several items mothers may choose from for
completing the survey). Telephone respondents are also offered a choice of rewards. Incentives
and rewards are used to maximize participation in the study.

Public health relevance
Oklahoma Pregnancy Risk Assessment Monitoring System (PRAMS) Component A Core Surveillance Project Narrative The overall goal of PRAMS is to reduce maternal and infant morbidity and mortality. Data gathered by PRAMS are used to: 1) document trends in adverse birth outcomes and other reproductive health and MCH outcomes; 2) identify subpopulations at greatest risk for the adverse birth outcomes, and inform prevention strategies and program development; 3) inform the Title V needs assessment process to help states plan for and allocate MCH block grant funds and to provide background information for states that apply for other grant funds; 4) develop and evaluate programs and policies that support improvement of maternal and child health; 5) investigate merging issues in reproductive health; and 6) support health professionals to incorporate the latest research findings into their standards of practice. Relevance to Public Health Oklahoma PRAMS data contribute to maternal and child health planning and decision-making state-wide. The information derived from PRAMS furthers the core public health function of assessment for pregnancy-related health issues in Oklahoma. Oklahoma PRAMS data are routinely used in the assessment of maternal and infant health status, determining accessibility of preconception, pregnancy, and postpartum services, examining prevalence of emerging health issues, and in the identification of maternal and infant health hazards.